New tools for antimalarial target identification

Target identification is a vital step in the drug discovery process and represents a substantial hurdle to further
development when large numbers of hit compounds are identified by high throughput phenotypic screening. This
problem is especially challenging in the case of antimalarial drug discovery because of the prevalence of
unconventional targets such as hemozoin, the formation of which is thought to be inhibited by nearly half the
clinical antimalarials and many experimental compounds. A key feature of the success of these drugs is that
hemozoin is derived from host hemoglobin and is therefore not mutable, thereby reducing the ability of P.
falciparum to acquire resistance. Prior studies have shown that target identification is complicated by the fact
that the ability to inhibit abiotic synthetic hemozoin (-hematin) formation is a necessary, but not sufficient
predictor of hemozoin inhibition in Plasmodium falciparum malaria parasites and conversely, decreased
hemozoin formation in the parasite is not itself confirmation of direct inhibition of hemozoin formation. We
hypothesize that direct measurement of increased unsequestered heme together with decreased hemozoin in
the intra-erythrocytic parasite is the most consistent method of identifying hemozoin inhibitors and that the latter
cause characteristic perturbations of the heme detoxification pathway that can be exploited in target
deconvolution. We further hypothesize that these inhibitors occupy a distinct region of chemical space that can
be mapped in silico. To achieve our objectives, the following specific aims are proposed: 1) Develop
generalizable methods to measure and detect hemozoin inhibition in Plasmodium falciparum; 2) Use in silico
methods to map hemozoin inhibition in chemical space; and 3) Develop a model of the full heme detoxification
pathway. To realize these aims, the research will be conducted as a collaborative and synergistic project between
Timothy Egan at the University of Cape Town (UCT), Katherine de Villiers at Stellenbosch University (SU), South
Africa and David Fidock at the Columbia University Medical Center (CUMC), New York, NY. Generalizable
analytical methods for measuring unsequestered heme will be developed at UCT and transferred to CUMC for
investigation of compound collections available at that site. A laboratory strain expected to exhibit universally
reduced susceptibility to hemozoin inhibitors will be generated at CUMC. In silico methods for mapping -hematin
inhibitors will be developed at SU and screening via molecular docking performed at UCT. Validation of these
methods will take place at UCT and SU. The input data for modeling the heme detoxification pathway will be
collected at UCT, while the mathematical model of this pathway will be developed at SU. Validation of the model
will be conducted at UCT and CUMC. We expect that this work will transform our ability to discern the role of
hemoglobin degradation and hemozoin synthesis in the mode of action of antimalarials, and provide vital tools
to identify novel inhibitors that are refractory to a rapid gain of resistance and can treat multidrug-resistant P.
falciparum malaria.

Public health relevance
Thousands of compounds with activity against Plasmodium falciparum malaria parasites have been discovered in recent years, but identifying the targets of these compounds, essential for their further development as antimalarial drugs, remains a major challenge. We propose new methods for detecting targets involving the parasite’s essential heme detoxification pathway. The development and implementation of generalizable analytical and computer-based methods will transform our ability to identify targets in this pathway and gain insights into the role of hemozoin formation in the mode of action of first-line antimalarial drugs.